Mechanisms of specification, quiescence, and regeneration of primordial germ cells

Project Summary
The camera on our main research microscope has failed and we are functioning only through a
loaner from our microscope representative. We request support through this administrative
supplement mechanism to replace the 5-series camera and upgrade the system from Windows
7, ZenLite imaging software. This microscope and camera are our workhorses in the lab for
imaging microinjections and micromanipulations, live embryo imaging, whole mount immune
localization and RNA-hybridization imaging. We can function only as long as the representatives
from Zeiss allow us to keep the loaner camera. The research supported by this request is
focused on understanding the mechanisms of formation of primordial germ cells during
embryogenesis, how they form during early development, and how they regenerate when the
originals are removed. Our work leverages embryos from a sister group to chordates – the sea
star and sea urchin. While not common organisms for biomedical research, these echinoderms
have many strategic benefits for revealing unique perspectives in the biology of germline
formation and regeneration. Millions of synchronous embryos from a single male/female cross
allow biochemical and metabolic analysis of the germline, the resultant embryos have ideal
transparency for in vivo longitudinal imaging, they develop rapidly, are easy to manipulate
(single cell drop-mRNA-seq, optogenetics, cell and tissue transplantations) and they are well
suited to complementary gene perturbation approaches (CRISPR/Cas9, morpholino antisense
oligonucleotides, MASO), and small molecule perturbations. The existing deep genomic and
reagent resources for these animals, coupled with their tractable experimental characteristics,
yields a unique system for understanding primordial germ cell biology with defined molecular
and morphological endpoints, in live embryos with longitudinal analysis, distinct metrics of
quantitation, and transgenerational evaluations.

Public health relevance
Project Narrative We request support through this administrative supplement mechanism for an upgraded imaging system to replace our currently non-functional camera and outdated imaging software. We are currently using a loaner camera to maintain critical, but minimal, imaging capabilities. The research supported by this request is focused on understanding the mechanisms of formation of primordial germ cells during embryogenesis, a process essential for sexual reproduction in animals.